Perceptual effects of processing and transmission delay in hearing technology

PROJECT SUMMARY/ABSTRACT
Next-generation hearing assistive technology will be driven by digital processing and digital connectivity, but
both can introduce disturbing delays. Advanced signal processing algorithms like noise reduction and
dereverberation perform best when they are allowed longer processing delay, and digital wireless devices like
remote microphones can greatly improve intelligibility but introduce significant transmission delays. Today,
hearing aids use strict delay constraints of about ten milliseconds in all conditions. However, listeners might be
able to tolerate greater delay in some conditions, especially in exchange for higher-quality signals. A better
understanding of tolerable limits for processing delay and transmission delay would help engineers to develop
innovative digital algorithms and system architectures for hearing technology.
This project will measure delay tolerance under realistic conditions using a set of experiments in which two
subjects hold a spontaneous conversation using hearing devices with variable delays. First, the researchers will
validate this new protocol and compare it against conventional listening and speaker tasks. Next, the researchers
will measure tolerable transmission delays for wireless remote microphones, which have been shown to
dramatically improve intelligibility in noise but are limited by the high latency of digital wireless protocols like
Bluetooth. Finally, they will study the effects of environmental noise and reverberation on delay tolerance. If
users can tolerate greater delay in challenging noisy and reverberant environments, then algorithms could
dynamically adjust their delay and enhancement performance based on acoustic conditions.
Delay is arguably the greatest technical roadblock to developing innovative connected hearing systems that could
dramatically improve quality of life for people with hearing loss. Before technology developers can hope to
address the technical challenges, they must better understand the perceptual constraints and tradeoffs.

Public health relevance
PROJECT NARRATIVE Digital signal processing and digital wireless standards are critical to current and future hearing aids and other hearing assistive technologies, but both introduce delays that may be disturbing to listeners. This project will characterize the perceptual effects of delay in realistic conditions, including noise and reverberation, for both hearing aids and wireless devices. The results will provide guidelines to engineers developing the next generation of connected hearing technology, which could dramatically improve quality of life for people with hearing loss.